Transcriptome-wide association studies for Alzheimer’s disease integrating RNA splicing and gene expression from multiple tissues

ABSTRACT
Alzheimer’s disease (AD) is the most common form of neurodegenerative disorder with over 47 million
people affected worldwide and a global economic impact estimated at about US $818 billion. Although
genome-wide association studies (GWAS) have identified over 30 susceptibility loci associated with
Alzheimer’s disease, the mechanisms of neurodegeneration are still poorly understood. To further
explore the missing heritability, transcriptome-wide association studies (TWAS) using gene expression
and splicing data have been performed to quantify associations of genetically predicted expression and
splicing (as a linear combination of genetic variants) with AD. Splicing disruption is a widespread hallmark
of AD and hundreds of aberrant pre-mRNA splicing (disruption) events have been reported to be
reproducibly associated with AD. Recent studies showed that integrating expression or splicing
information across multiple tissues into TWAS could significantly improve the chance of discovering
genes susceptible for complex traits. Splicing events in a gene can be highly correlated. However,
existing statistical methods for TWAS do not account for correlation among splicing events, and thus may
result in loss of power in detecting disease genes. In addition, studies have shown that most splicing
Quantitative Trait Loci (sQTL) acted independently from expression QTLs (eQTLs) when exerting
influence on some complex diseases. Therefore, jointly analyzing the effect of eQTLs and sQTLs in a
gene may increase power to detect disease genes. In our parent R01, we proposed joint expression and
splicing TWAS methods that combine the effects of eQTLs and sQTLs in a gene across multiple tissues
by a sampling method (sampling around 107 times), while accounting for the correlation among splicing
events and between splicing and expression. However, when the number of tissues is very large the
sampling method can be computationally intensive. Therefore, it is necessary to develop computationally
efficient joint TWAS methods to handle a large number of tissues. The objective of this study is to develop
computationally efficient TWAS methods to integrate splicing and gene expression information across
multiple tissues and apply the methods to identify novel susceptibility genes for Alzheimer’s disease.
Specifically, we will 1) develop computationally efficient TWAS methods that analyze joint effect of
splicing and gene expression and leverage information from multiple tissues, and 2) apply the TWAS
methods proposed in Aim 1 to the analysis of Alzheimer’s disease data. We will account for correlation
among splicing events and between splicing and gene expression in a gene across multiple tissues. We
expect that the proposed methods have higher power in detecting susceptibility genes for AD than
existing methods. The proposed methods can also be applied to other complex diseases.

Public health relevance
Narrative: In this project, we propose methods that use RNA splicing and gene expression data from multiple tissues and genome-wide association studies (GWAS) data to discover genes responsible for the development of complex diseases. We will apply these methods to the analysis of Alzheimer’s disease (AD) data. The study have a good potential to identify novel susceptibily genes for AD and improve our understanding of the genetic/molecular mechanisms of neurodegeneration in AD.